Training in Child Health Services Research and Implementation Science

ABSTRACT
The Harvard-wide pediatric HSR Fellowship is a 30 year collaboration of Boston Children’s Hospital,
Massachusetts General Hospital for Children, and the Harvard Department of Population Medicine/Harvard
Pilgrim Healthcare Institute. This program has an amazing training record- the 154 alumni include 18
graduates from race/ethnicity groups underrepresented in medicine, 61 in leadership positions including 16
CMOs or Senior VPs, and four elected to the National Academy of Medicine. The curriculum is grounded in
rigorous child health services research training and in-depth implementation science training, aligned with
AHRQ learning health system (LHS) competencies. While our multisite collaborative leadership structure has
remained constant for two decades, our list of multidisciplinary, innovative faculty is updated regularly.
Pediatric HSR training programs are needed because critical epidemiologic, fiscal, and workforce differences,
such as a mental health crisis or a relative dearth of quality measures and interventions, set pediatrics apart
from adult medicine. Our overarching aim remains: to provide outstanding, comprehensive training across the
spectrum of pediatric health services research methods that both advances understanding of equitable health
and healthcare systems, and tests and evaluates implementation of novel approaches that demonstrably
improve child health. Toward this aim, the objectives for this fellowship are to: 1) recruit and retain diverse
candidates; 2) provide exemplary training in health services research and implementation science within LHS;
3) support our dedicated faculty; 4) continuously improve the training program and update the curriculum; and
5) continue to develop diverse graduates to lead the nation in innovative pediatric health services research,
including research that accelerates the development of LHS. To meet this goal, training focus areas include:
cutting edge and emerging methods in health systems research; application of implementation science and
related methods; LHS competencies including embedded research and health equity research within health
systems; and patient and family-centered research. The program will support 7 postdoctoral trainees per year
for the 2-year postdoctoral fellowship to create a critical mass of trainees across subspecialties, areas of
research, and methodological domains. In addition to conducting closely mentored research, each trainee will
complete coursework from the Harvard T.H. Chan School of Public Health for core skills of biostatistics and
epidemiology and participate in advanced health services research methods training. Over the past 30 years,
our program has evolved in response to feedback from trainees, faculty, and our advisory board. In this cycle,
we will expand LHS training consistent with AHRQ’s new health equity and embedded research competencies
and add an alumni mentoring program. Renewal of our T32 Program will address a critical deficiency in the
pediatric subspecialist and generalist healthcare delivery system scientists that will foster the development and
success of learning healthcare systems to improve child health.

Public health relevance
PROJECT NARRATIVE The Harvard-wide pediatric Health Services Research (HPHSR) Fellowship is a 30 year collaboration of Boston Children’s Hospital, Massachusetts General Hospital for Children, and the Harvard Department of Population Medicine/Harvard Pilgrim Healthcare Institute. Our multidisciplinary, well-funded faculty provide exemplary training in pediatric health services research and implementation science within leading health systems. This program has an amazing training record- the 154 alumni include 18 graduates from racial or ethnic groups underrepresented in medicine, 61 in academic or research leadership positions including 16 CMOs or Senior VPs, and four alumni elected to the National Academy of Medicine